Commercialization of automated mobile device for accurate comprehensive refraction

Summary
The goal of this CRP SBIR application is to commercialize QuickSee Plus that was researched and
developed during SBIR Phase 2 work. QuickSee Plus, will be a unique tool for eye care professionals that
enables comprehensive refraction (objective and subjective) in a single, portable package. It will provide
tremendous value for eye care professionals as it improves their efficiency within the clinic and extends
their reach outside the clinic, thereby, greater accessibility to refractive eye care for health disparity
populations

Public health relevance
Narrative This project proposal seeks to commercialize novel technologies that will disruptively increase the accessibility of both objective and subjective refractive eye examinations outside of the clinic. Specifically, the design-for-manufacturing, regulatory and manufacturing preparation work that is required to bring QuickSee Plus to market will be performed. The goal is make the technology commercially so that it can used by eye care professionals to provide accurate, comprehensive refractions, hence improving access to vision correction globally.